Traditional and New Dietary Assessment Methods (TANDAM) for Personalized Nutrition

PROJECT SUMMARY/ABSTRACT
Errors in dietary assessment methods attenuate the association between diet and chronic disease outcomes,
such as obesity and cancer, which derails efforts to aggressively pursue policies directed to improving dietary
intakes in the population. Harnessing the capabilities of mobile-based and image-based technology tools offer
an opportunity to reach a wide audience via cost-effective, convenient, timely, and familiar channels. Properly
constructed and validated, these tools would eliminate the labor-intensive coding required for traditional paper
and interview methods. Successfully creating tools which tap into several specialty areas of science and behavior
requires a multidisciplinary team of scientists. For several, the research group represented in the proposal have
been committed to advancing dietary assessment methods. We have made progress with harnessing the
availability of the ubiquitous and popular mobile telephone, passive methods, and the Automated Self-
Administered 24-Hour Dietary Assessment (ASA24). Our research group represents a partnership between
nutrition scientists/epidemiologists, engineers specializing in image analysis, Registered Dietitians, and
biostatistions. Having completed multiple studies demonstrating the efficacy of the Technology Assisted Dietary
Assessment (TADA) system through the use of the mobile food record (mFR) app, we recognize the value of
having multiple validated tools available to better accommodate diverse research questions, variations due to
age or levels of cognition. The Nutrition for Precision Health powered by the All of Us Research Program provides
a unique opportunity to test multiple methods of dietary assessment using modern and novel methods. To fully
take advantage of this opportunity, we will deploy ASA24 web-based tool; the Mobile Food Record (mFR), an
image based app; and a passive method, the Automatic Ingestion Monitor v2 (AIM-2). Further, we will combine
methods and include the ASA24 as a dietary record and the ASA24 combined with the mFR. Advancing
technology tools would facilitate precision dietary assessment and research translation to better comprehend
eating behaviors, define diet-disease relationships, and assess the effectiveness of intervention programs.

Public health relevance
PROJECT NARRATIVE Elevating dietary assessment through harnessing the capabilities of computers, mobile-based, and image- based technology tools which offer an opportunity to reach a wide audience via cost-effective, convenient, timely, and familiar channels.